Mechanisms of RNA localization and translational regulation on the endoplasmic reticulum

The endoplasmic reticulum (ER) is the subcellular site of secretory and membrane protein synthesis
and performs critical functions in secretory/membrane protein biogenesis and cellular proteostasis. In addition
its established role in secretory/membrane protein synthesis, recent studies examining the mRNA
transcriptomes of cytosolic and ER-bound ribosomes reveal that cytosolic protein transcripts are broadly
represented on the ER, with ribosome footprinting analyses demonstrating translation of cytosolic protein
mRNAs on ER-associated ribosomes. These findings identify an unexpected mRNA transcriptome-wide
function for the ER in proteome expression and reopen fundamental questions regarding the mechanisms
regulating mRNA localization and translation on the ER. Principally, where current models posit that mRNA
localization to the ER is co-translational and signal sequence-dependent, the abundant presence and
translation of cytosolic protein mRNAs on the ER indicates that either alternative and/or multiple pathways
mediate mRNA localization to the ER. As well, and although SRP pathway function in protein translocation is
well established, the question of SRP pathway function in mRNA localization to the ER remains largely
unexplored. Also of significance, the recent findings that a number of translocon-associated proteins, including
Sec61α,β, TRAPα, ribophorin I, and p180, are mRNA binding proteins (RBPs) suggest previously
unappreciated roles for ER resident RBPs in the biology of RNA localization and translation on the ER.
This proposal merges three primary research themes of our laboratory; SRP pathway function in mRNA
and ribosome localization to the ER; ii) ER-localized translation initiation as a mechanism of localized protein
synthesis, and iii) RNA binding protein function in RNA localization and translational regulation, to address new
questions regarding cellular mechanisms of mRNA and ribosome localization to the ER. Building on the past
decade and a half of our research into RNA localization and translational regulation on the ER, including
founding evidence identifying an mRNA transcriptome-wide role for the ER in cellular proteome expression, the
proposed research will utilize mammalian tissue culture cell systems, gene editing and silencing approaches,
RNA-seq and Ribo-seq transcriptome analyses, HITS-CLiP and PAR-CLIP studies of ER RNA binding proteins
and their RNA interactomes, and biochemical analyses of the subcellular organization of the translation
machinery, to obtain new insights into the cellular organization and regulation of proteome expression. This
research is expected to advance understanding into the systems and pathways governing post-transcriptional
gene expression in the cell. In emphasizing in vivo analyses and native biosynthetic approaches to the study of
RNA and ribosome trafficking dynamics, this research is significant in its efforts to rigorously test existing
paradigms and advance understanding of cellular mechanisms of localized protein synthesis.

Public health relevance
Relevance: Mammalian cells use biological zip codes to transport mRNAs, which encode the information for the synthesis of proteins, to specific locations in the cell, so that proteins are made in their appropriate location. This RNA localization process is critical to early development, learning and memory, and at the level of the individual cell, to the secretion of hormones and neurotransmitters as well the cell surface localization of proteins functioning in signaling and cell-cell communication. The findings from this study are expected to reveal new mechanisms of RNA localization and identify conserved pathways that may be dysregulated in diseases of development, metabolism, and ageing.